The Clinical Research/Reproductive Scientist Training Program (CREST)

Project Summary
The Clinical Reproductive Endocrine Scientist Training Program (CREST) has trained 61 physician scientists
to conduct clinical research, and has directly enabled these physicians to participate in multicenter clinical trials
and secondary data analyses. By providing a combination of didactic training, critical networking and
sponsorship, and biostatistical support, we have demonstrated how to forge a productive investigative career
pathway for clinically active physicians in reproductive medicine. We propose to build upon our successes to
further strengthen this program over the next 5 years. The following specific aims will be addressed: Aim 1:
Complement and/or enhance the training of a workforce to meet the nation's biomedical, behavioral
and clinical research needs. We propose to continue formal didactic training of up to 6 Scholars in
Reproductive Medicine per year in clinical research methodology, using unique, customized online modules
adapted from the Duke University Clinical Research Training Program, and complemented by in-person
didactics and one-on-one consultation. To this we add resources for the completion of a capstone, `thesis'
project to provide a mentored hands-on research experience. Aim 2: Enhance the diversity of the
biomedical, behavioral and clinical research workforce. CREST will maintain and improve its track record
of successful recruitment of women and underrepresented minorities (URMs) in excess of their representation
within our field. Aim 3: Help recruit individuals with specific specialty or disciplinary backgrounds to
research careers in biomedical, behavioral and clinical sciences. We shall continue to enhance the above
resources by providing specific career development opportunities in partnership with the American Society for
Reproductive Medicine, including committee representation, training in leadership and team management
skills, and networking opportunities to provide long-term benefit to participants that will perpetuate the program
and allow Scholars to continue to conduct research in reproduction. A formal evaluation program will be added
to our informal evaluation processes as we seek continuous improvement.

Public health relevance
Project Narrative Physician scientists face an adverse funding environment, a situation that is even more challenging in reproductive medicine due to intense competition for ever-shrinking funds. By providing enhanced training, networking, and infrastructure support, the CREST program has sparked and maintained careers in reproductive medicine. We propose to build on this success to further increase the program's effectiveness.